The Effects of Insurance Benefit Design Innovation on Patient Health

Abstract
My research in health economics has focused on how information and targeted consumer cost-sharing
influences how patients choose providers and the financial savings of incentivizing patients to choose low-price
providers. I have also examined the opposite side of the market, how patient use of information and targeted
consumer incentives spurs provider price competition. These topics provided the framework for my research as
a PhD student in Health Economics at the University of California, Berkeley and I continue to build on these
topics while a policy researcher at the RAND Corporation. A natural next step for my career is to expand this
line of research but in a more in-depth manner and using more advanced statistical methods. Performing
mentored research in these areas will help me successfully make the transition from directed to independent
research. The proposed study will help me to (1) contribute to a deeper understanding of patient health effects
of an innovative insurance benefit design that is particularly relevant for the aging population; (2) continue to
build capabilities working with large medical claims data sets and develop expertise in innovative statistical
methods from different disciplines; (3) gain training in aging-related health-services research; (4) expand my
exposure to the aging, health economics, and health services research communities; and (5) develop my
abilities as an independent health services researcher and build the foundations to successfully compete for
R01-level grants.
In this project, I propose to examine whether reference pricing for colonoscopies and pharmaceuticals
decreases adherence to recommended colorectal cancer screening and medication therapies among the near-
elderly population. I will also examine the impact of reference pricing on patient health outcomes and the aging
process. To do so, I intend to apply novel machine-learning statistical methods that have been recently
developed in the computer science and statistics fields. As part of this proposal, I have built a formal training
plan to develop expertise in these methods. This project will provide me with the flexibility and support to
develop a long-term research agenda that focuses on using innovative statistical methods to evaluate the
comprehensive effects of consumer cost- sharing programs. Although this study focuses on a single cost-
sharing program, reference pricing, the skills I gain through this award will allow me to independently lead
evaluations of future benefit designs. The application of machine-learning methods to the setting of reference
pricing will provide a framework that I or other researchers can use to evaluate other insurance benefit designs
or alternative patient populations.
!

Public health relevance
Narrative An increasingly popular insurance benefit design, reference pricing, provides targeted financial incentives for consumers to receive care at low-cost providers. While the financial savings from reference pricing programs are well-known, the health impacts have yet to be studied. The proposed career grant will apply machine learning techniques to develop a long-term research agenda focused on understanding the patient health effects of reference pricing for colonoscopies and medication therapies, which are services that are especially relevant for the aging population. !